A prospective multiethnic HFpEF cohort from California's Central Valley

ABSTRACT
This is an application requesting for an Administrative Supplement to Enhance Diversity for the NIH U01
HL160274 grant. The proposed combined clinical and bioinformatics studies, although within the scope of the
parent grant, are not in the funded Specific Aims. The long-term goal of the candidate is to pursue a career as a
physician-scientist with a focus on servicing underserved communities. This supplement aims to obtain new
insights on how correlate to heart failure with preserved ejection fraction (HFpEF) risk factors by building upon
the existing aims from the parent award. This application will test the overarching hypothesis that
sociodemographic factors at the population and individual levels, social determinants of health (SDoH) are
mechanistically linked to HFpEF phenotypes, comorbidities, and their molecular underpinnings. the proposed
study will obtain retrospective and prospective clinical data and blood samples from HFpEF patients with distinct
SDOH risk. The potential molecular mechanisms will be tested using multi-omic data in HFpEF patients
subjected to SDOH factors. By understanding the SDOH contributions, we will gain insights into patient-specific
treatment to improve their long-term health outcomes. The candidate and the mentors have outlined a
comprehensive training goal and have assembled a strong Mentoring Team to ensure that the candidate will
receive valuable technical training, research experience, and career development. Therefore, this proposed
supplement will provide the candidate a platform for career development while, in parallel, fostering diversity by
reducing underrepresentation in the workforce of scientific research, as outlined in the FOA. New insights
obtained from the proposed supplement will highly complement and enhance the project in the parent grant.

Public health relevance
Project Narrative This is an application requesting for an Administrative Supplement to Enhance Diversity for the NIH U01 HL160274 grant. The proposed combined clinical and bioinformatics studies, although within the scope of the parent grant, are not in the funded Specific Aims. Our proposed study promises to contribute both technically and conceptually to the overall understanding of the molecular mechanisms underlying HFpEF patients in underserved communities.